Development of a novel protein depletion method in Chlamydia

Project Summary/Abstract
More than 1.8 million cases of Chlamydia trachomatis infections are reported to the
CDC each year, making it the most commonly reported infectious disease in the country.
This pathogen is an obligate intracellular bacterium that can only reproduce in human
cells. As a result of this dependence on a host cell, Chlamydia has undergone reductive
evolution and has one of the smallest of bacterial genomes. Many of the remaining
genes, including Chlamydia-specific genes, are essential genes whose functions have
not been elucidated because of the limitations of current genetic methods. To study
chlamydial gene function, we are developing a novel protein depletion method that
exploits the ability of small RNAs (sRNAs) to downregulate expression of specific target
proteins. In proof-of-principle experiments, we have shown that we can inducibly
knockdown protein levels for two chlamydial proteins, IncA and IncG. In Aim 1, we will
knockdown additional C. trachomatis genes, including non-essential and essential
genes. In Aim 2, we will compare this sRNA knockdown method to another protein
depletion method, CRISPRi. We will compare the ability of each method to control the
level and timing of knockdown and will investigate whether they cause polar effects on
genes within the same operon. Successful completion of these studies will lead to an
innovative genetic approach for selectively depleting a Chlamydia protein. This new tool
for studying chlamydial gene function will have a sustained impact on the field.

Public health relevance
Project Narrative Chlamydia is a major cause of sexually transmitted infections in the U.S., and more cases of chlamydial genital infections are reported to the CDC than any other infectious disease. This project will develop a novel protein knockdown method in C. trachomatis that is based on the use of a reprogrammed small RNA to selectively deplete levels of a target protein. This method will provide a new genetic tool for studying the function of chlamydial proteins.